TRANSITION TASK ORDER FOR FFRDC CONTRACT

This is to cover costs associated with the transition of one contract to the other for the operation of the NCI’s Federally Funded Research and Development Center (FFRDC).